Administrative Core

ADMINISTRATIVE CORE: Abstract
The Diabetes Research Center (DRC) of the Joslin Diabetes Center is a driving force in promoting scientific
progress in the field of diabetes and related metabolic disorders at Joslin and in the surrounding Harvard
Medical School (HMS) community. Funding for the DRC enables state-of-the-art Biomedical Research Core
facilities, a Pilot & Feasibility Program that supports new and innovative research, and an Enrichment Program
that serves as a stimulating platform for scientific exchange. These activities are organized and managed by
the Administrative Core. Within this Core, the team of Director and Associate Directors brings a strong and
informed vision of diabetes research. Together they develop, oversee, and integrate Center activities, with
input from an engaged Internal Advsory Committee and external diabetes research experts who serve on the
DRC External Advisory Committee. The Administrative Core serves a key role in coordinating Center activities
with the administrative and scientific leadership at Joslin, Boston-area institutions, other DRCs, and the
NIDDK. The broad and deep expertise of the Joslin DRC leadership team, combined with rigorous and regular
self-assessments of the Center, enable the DRC to evolve Center activities nimbly to embrace new scientific
advances and the development of new technologies.